Validation of the disease-protective effects of pristimerin in EAE models with complementary characteristics

Background: Multiple sclerosis (MS) is an autoimmune disease of the central nervous system characterized
by demyelination of the axons, leading to weakness and paralysis of the limbs and other symptoms. Many
potent drugs are currently in use for MS, but drawbacks such as limited efficacy, reduced responsiveness,
severe adverse effects and high expense create an urgent need for new MS therapeutic agents. Over
decades, natural plant products have served as an invaluable source for new drugs. However, this potential
resource has not been fully exploited for MS treatment. In a recent study using the myelin oligodendrocyte
glycoprotein-induced murine experimental autoimmune encephalomyelitis (MOG-EAE) model of human MS,
we observed that pristimerin, a natural plant-derived triterpenoid, is highly effective in suppressing the
development (early therapy) and progression (late therapy) of the disease. Pristimerin targeted key mediators
of disease pathology (e.g., pro-inflammatory cytokines and a neurotrophic factor) in the spinal cord of MOG-
EAE mice. Based on these significant results, Veterans Affairs (VA) has filed a patent application on the use of
pristimerin as a novel therapeutic for MS. We now propose validating our preliminary findings in a second
mouse model of EAE via this BLR&D pilot funding mechanism, in response to Validation RFA BX24-044.
Objectives: To further strengthen and de-risk the translation of these novel pre-clinical findings to MS therapy,
[we plan to test pristimerin in a relapsing-remitting EAE model in SJL/mice, whose genetics, antigen
specificity, and clinical features are complementary to that of chronic progressive MOG-EAE model in C57BL/6
mice. The relapsing-remitting disease represents the most common (85%) type of human MS.]
Hypothesis: Based on our initial study in the MOG-EAE model, we anticipate that [pristimerin will inhibit
disease progression and controls relapses in the relapsing-remitting EAE model.] We further suggest that
pristimerin inhibits EAE by reducing T helper 17 (Th17) activity/ differentiation (and altering the Th17/regulatory
T cell balance) and [by reducing the activity of disease-associated microglia (DAM) (and restoring the balance
in favor of homeostatic microglia (hMG)).] Finally, by suppressing the pro-inflammatory effects of cytokines
and chemokines on these cells, pristimerin may have profound effects on disease management/ progression.
We will use state-of-the-art methodology to address these propositions, including sc-RNA-Seq and proteomics.
Specific Aims: Aim 1. Validate the disease-protective effect of pristimerin [administered either
intraperitoneally or orally in relapsing-remitting EAE model] and determine its pharmacokinetics (PK) and
multiorgan toxicity in both EAE models. Aim 2. Define the mechanisms by which pristimerin induces changes
in the activity of Th17 and microglia in both EAE models. [In collaboration with experts in MS (H. Rus), neuro-
inflammation (B. Stoica), and PK (R. Lapidus), we are well positioned to rigorously validate pristimerin in EAE
mice, to further advance it for investigational new drug (IND)-enabling studies for eventual use in human MS.]

Public health relevance
Multiple sclerosis (MS) is a chronic, debilitating disease affecting the brain and spinal cord. Veterans are among the approximately one million Americans affected by MS. MS prevalence is much higher in women than in men, which is relevant given the increasing numbers of women now serving in the military. Despite the availability of several drugs, many MS patients do not respond well to existing pharmaceutical options, often suffering severe adverse effects. Thus, new therapeutic agents for MS are urgently needed. Using an animal model of MS, we recently observed that pristimerin, a natural plant product, can inhibit the development and progression of experimental MS. To de-risk the translation of this finding to MS patients, we need to validate the therapeutic effects of pristimerin [in a relapsing-remitting model of MS, with characteristics that are complementary to the chronic progressive disease model already tested.] This validation is critical for seeking approval of the U.S. FDA for testing pristimerin in human MS, being facilitated by our proposed pilot study.